New Drosophila, mouse, and human podocyte models to study HIV-APOL1-G1 associated chronic kidney diseases

PROJECT SUMMARY/ABSTRACT
People living with HIV (PLWH) carrying any combination of two APOL1 risk alleles (RA), named G1 and G2, are
at high risk of developing HIV-chronic kidney diseases (HIV-CKD), even when treated with antiretroviral therapy
(ART). A critical gap in knowledge that remains to be understood, is how APOL1-G1/G1GM, the most common
RA in people with HIV-nephropathy (HIVAN) living in the US, including children and adolescents, interact with
HIV-genes to precipitate CKD. We have developed Tg flies carrying APOL1-G1 derived from a child with HIVAN,
specifically in nephrocytes (the equivalent of mammalian podocytes) and found that APOL1-G1 affects the
endocytic activity and size of these cells precipitating their death. In addition, we developed dual APOL1-G1-
HIV-Nef Tg flies and showed that both act in synergy to increase the workload of nephrocytes, affecting several
trafficking and degradation pathways that accelerate their death. We also developed APOL1-G1-Tg mice driven
by the APOL1-G1 promoter/enhancer sequences cloned from a child with HIVAN and showed that interferon-γ
increased the expression of APOL1-G1 in podocytes and induced proteinuria. Furthermore, we found that (a)
HIV-1 enters podocytes cultured from the urine of children with HIV-CKD via endocytosis and induces the
expression of APOL1-G1; (b) APOL1-G1 is localized mainly in the perinuclear region and endoplasmic reticulum
(ER) in these cells; (c) APOL1-G1’s ER localization in cis and trans orientation can induce cytotoxicity in HIVAN
podocytes; (d) SNARE proteins and the autophagy pathway play a key role regulating the toxicity of APOL1-G1
in fly nephrocytes. Based on these data, we hypothesize that HIV gene products and cytokines precipitate HIV-
CKD by inducing the expression of APOL1-G1 in podocytes affecting its interactions with SNARE proteins and
cell trafficking molecules. In turn, we propose that APOL1-G1 acts in synergy with HIV to impair the balance
between key autophagy and ER stress pathways, thus disrupting the homeostasis of podocytes and causing
proteinuria and CKD. This hypothesis will be tested in two aims. In aim 1 we will define new mechanisms through
which APOL1-G1 interacts in vivo with HIV-genes to affect the structure, function, and survival of nephrocytes in
dual Tg flies carrying APOL1-G1 plus HIV-env and all other HIV-accessory/regulatory genes. In aim 2, we will
determine how APOL1-G1 and HIV interact in new dual APOL1-G1 Tg mice driven by the APOL1-G1 promoter
cloned from a child with HIVAN and in cultured HIVAN podocytes. Here we will expand and validate the most
relevant findings and cell trafficking, autophagy, ER, and inflammatory pathways identified in the HIV-G1Tg-flies.
Renal samples, primary mouse/human podocytes, and HIVAN podocyte cell lines modified by a CRISPER/Cas9
genome editing fluorescent tagging approach will be used to assess the endogenous localization and toxicity of
APOL1-G1 and HIV-genes, and to validate all key findings generated in the fly and mouse models. This study
will generate new experimental model systems to study the pathogenesis of HIV-CKD, perform high throughput
genetic screenings, identify new mechanisms or therapeutic targets, and test new drugs to treat HIV-CKD.

Public health relevance
PROJECT NARRATIVE People living with HIV carrying two alleles of a risk variant gene named APOL1-G1 are at very high risk of developing HIV-chronic kidney diseases (HIV-CKD) and kidney failure, even when treated with antiretroviral therapy (ART). The mechanism is not clearly understood and has not been investigated in enough depth. Here will generate and validate new experimental fly, mouse and human cell culture model systems to identify new mechanisms through which APOL1-G1 and HIV-1 interact to precipitate HIV-CKD, perform high throughput genetic screenings, discover new therapeutic targets, and test new drugs to treat HIV-CKD.